Identifying long-range polarity cues using spontaneous mutations in mammals

Project Summary/ Abstract
Neural tube closure defects and congenital heart defects are common developmental disorders, affecting 1 in
1000 and 1 in 100 live births, respectively. During embryonic development, cells must be able to sense
direction and coordinate collective behaviors to avoid these severe malformations. Although the signaling
pathway that imparts directionality between neighboring cells is known, uncovering the mechanisms that
transmit this information on the order of thousands of cells has stalled. Fortuitously, spontaneous mutations in
small mammals have given rise to animals that are prized for region specific disruptions in fur orientation. I
hypothesize that the mutations disrupt long-range directional cues. The objective of this proposal is to utilize
spontaneous mutations to identify long-range directional cues in the mammalian epidermis. This work will shed
light on the etiology of complex congenital diseases, which will assist in the development of in utero therapies
and the generation of artificial organs.
A key molecular pathway that allows cells to communicate directional information is the Planar Cell
Polarity (PCP) pathway, without which severe developmental defects arise. The core pathway consists of three
transmembrane proteins that form asymmetric complexes that are localized to opposite sides of a cell.
Through both positive extracellular feedback and negative intracellular feedback, this asymmetry is propagated
locally but the mechanism that orients asymmetry across entire tissues is poorly understood. Although the core
pathway components were identified through forward genetic screens in Drosophila, this method has been less
successful in uncovering global polarity cues. The mouse skin provides an ideal system to identify long-range
polarity cues. The expansive tissue is decorated with thousands of hair follicles (HFs) that are all oriented in
the same direction through a PCP driven process. Remarkably, we showed the back skin is compartmentalized
into regional domains that influence the direction of PCP signaling. This data suggests that region specific
long-range cues cooperate to coordinate PCP and HF orientation across the entire tissue. In support of this
idea, spontaneous mutations in small mammals produce animals with distinct, region-specific disruptions in
hair follicle orientation. To investigate whether these mutations affect long-range polarity genes, I will identify
the causative mutations through genomic sequencing and characterize the effect the mutations have on tissue
polarity using genetics and image analysis. I will then interrogate the ability of the identified proteins to act as
long-range polarity cues in vivo and in organotypic skin culture. Upon completion of this study, we will identify
and understand new mechanisms that coordinate collective behaviors across great distances during tissue
morphogenesis.

Public health relevance
Project Narrative During embryogenesis, cells must be able to sense direction and coordinate collective behaviors to avoid malformations such as neural tube closure defects and congenital heart disease. Although the signaling pathway that imparts directionality between neighboring cells is known, the mechanisms that transmit this information across tissues are not well understood. Using spontaneous mutations in small mammals that give rise to disruptions in fur orientation, we will identify long-range directional cues and shed light on the etiology of complex congenital diseases.